Melanocortin-3 receptor in feeding and anxiety neural circuits

PROJECT SUMMARY (See instructions):
Neural circuits modulating feeding, stress and anxiety must communicate with each other to maintain homeostasis.
Failure to appropriately respond to certain stressors can promote the development of maladaptive feeding behaviors
observed with obesity and metabolic disorders. Despite an increasing prevalence of both metabolic and psychological
disorders, our understanding of the key inputs linking these behavioral states remains rudimentary. Melanocortin-3
receptor (MC3R) is ideally positioned, both anatomically and functionally, to mediate direct communication between
feeding and stress/anxiety circuits. Importantly, MC3R neurons bidirectionally regulate both feeding and anxiety, and
deletion of MC3R produces multiple forms of sexually dimorphic alterations in feeding, including anxiety-related
hypophagia. While it is evident MC3R impacts feeding and stress/anxiety circuitry in both male and female mice, the
sites driving these behaviors remain unknown. The bed nucleus of the stria terminalis (BST) is a highly differentiated
nuclear complex whereby autonomic, emotional and neuroendocrine signals are integrated and subsequently relayed
to hypothalamic and brainstem regions to regulate the expression of motivated behaviors, including feeding and
defensive actions. The BST is centrally involved in stress-related psychopathologies, such as pathological and
adaptive anxiety and modulates food intake and energy balance with both anorexic and binge-like eating effects. The
BST is also one of the most sexually dimorphic areas in the brain and thus may regulate sex differences observed in
numerous eating and stress-related clinical disorders. MC3R neurons and terminals are abundantly expressed in the
BST, and therefore BSTMC3R circuitry may function as an integration hub for information driving feeding, stress and
anxiety-like behaviors. Intriguingly, this crucial integrative hub also seems to be highly susceptible to developmental
perturbations that can have lasting health consequences. The K99 phase revealed the structure and function of the
mature BSTMC3R circuitry. The R00 phase will focus on determining how dietary and stressful perturbations during
critical periods of development may permanently alter the structure and function of BSTMC3R circuitry. The overall
hypothesis of this application is dietary and stressful perturbations during critical periods of development will disrupt
BSTMC3R neural circuitry, culminating in lasting consequences in feeding behavior and responses to stress.

Public health relevance
RELEVANCE (See instructions): Despite an increased prevalence of both feeding and anxiety disorders, the key neural inputs linking these two states, and the potential heterogeneity between males and females, remain poorly understood. This proposal will be the first step in defining the role of the melanocortin-3 receptor (MC3R) in the integration of feeding and anxiety which could ultimately lead to new therapeutic treatments for maladaptive feeding behaviors associated with obesity and eating disorders.